IGF::OT::IGF OTHER FUNCTIONS. HINTS Data Users Conference, 15 Years of HINTS: Lessons Learned & Future Directions. Period of performance 1/8/18 - 10/15/18.

The primary objective of this project is to provide a forum for researches to share analyses of HINTS data on a broad range of topics to help the scientific community better understand the root causes of certain health outcomes and plan more effective interventions for improving population health.